Targeting the Endothelial Glycocalyx to Enhance Vascular Function and Exercise-Induced Vascular Adaptations in Type 2 Diabetes

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) is the leading cause of death in Veterans with type 2 diabetes (T2D).
Lifestyle modifications, including increased physical activity, are recommended as first-line therapy for the
management of T2D. Unfortunately, the efficacy of these lifestyle interventions for preventing CVD morbidity
and mortality in patients with T2D is not well-established. Available evidence from our group and others
indicates that vascular adaptations to exercise training are impaired in subjects with T2D. We propose that
diminished vascular adaptations explain why increased physical activity does not lead to a robust reduction in
CVD morbidity and mortality in T2D. However, the mechanisms responsible for this deficit in vascular
adaptations to exercise in T2D remain unknown. This is a major limitation for identifying new adjuvant
therapeutics to maximize the cardiovascular benefits of exercise in the diabetic population. Exercise exerts
direct effects on the vasculature via repetitive exposure to hemodynamic stimuli or shear stress. The
increased blood flow and luminal shear stress attendant to each bout of exercise are primary mechanisms
contributing to vascular adaptations. Shear stress is detected by mechanosensitive endothelial luminal
structures, such as the glycocalyx, that convert mechanical forces into biochemical signals via
mechanotransduction. As such, we propose that an intact endothelial glycocalyx is required for the
mechanotransduction of increased shear stress and the subsequent chronic vascular adaptations associated
with exercise to occur. Notably, glycocalyx degradation is a classic feature of T2D. Accordingly, our
overarching hypothesis is that endothelial glycocalyx degradation is a key factor precluding shear stress
mechanotransduction and consequent exercise-induced vascular adaptations in T2D. The corollary to this
hypothesis is that restoration of the endothelial glycocalyx by dietary supplementation of glycocalyx precursors
(DSGP) will improve vascular adaptations to exercise in T2D. Specifically, in Aim 1 (Proof of Concept Clinical
Trial Phase), we will document that DSGP enhances endothelial glycocalyx integrity in patients with T2D.
Although we provide preliminary evidence that DSGP can increase glycocalyx thickness and endothelial
function in a mouse model of T2D, this will be the first study to demonstrate these effects in T2D subjects. The
effects of DSGP for eight weeks will be studied using a double-blinded randomized placebo control trial.
Subsequently, in Aim 2 (Expended Clinical Trial Phase), we will demonstrate the permissive role of the
endothelial glycocalyx in exercise-induced vascular adaptations in patients with T2D. Having shown that
restoration of the endothelial glycocalyx via DSGP is feasible in T2D subjects, we will now investigate whether
such supplementation will potentiate exercise training-induced improvements in endothelial function. This will
be accomplished in a factorial balanced design in which T2D subjects will be randomized to DSGP or placebo
with and without concurrent exercise training for eight weeks. Our team is poised to move cardiovascular and
diabetes research forward with a translational project that will exert a sustained, powerful impact across a
number of levels of inquiry that are novel conceptually, methodologically, and therapeutically. Indeed,
targeting the glycocalyx holds extraordinary promise for achieving optimal exercise-induced vascular
adaptations in Veterans with T2D, thus maximizing the cardiovascular benefits of exercise.

Public health relevance
PROJECT NARRATIVE The prevalence of type 2 diabetes (T2D) continues to increase in the US, with 26.8 million adults carrying a diagnosis. Importantly, T2D is widespread in the Veteran population, and the VA administration spends $1.5 billion annually in diabetes care. This epidemic of T2D also contributes to the staggering rates of cardiovascular disease and cardiovascular mortality. Lifestyle modifications, including increased physical activity, are recommended as first-line therapy for the management of T2D. Unfortunately, patients with T2D exhibit diminished vascular adaptations to exercise. The proposed project will test the overall hypothesis that degradation of the endothelial glycocalyx, a characteristic feature of T2D, precludes shear stress mechanotransduction and consequent exercise-induced vascular adaptations. As such, we pose that restoration of the endothelial glycocalyx via dietary supplementation of glycocalyx precursors will potentiate vascular adaptations to exercise in Veterans with T2D.